Gnotobiotic Core

PROJECT SUMMARY
The CGIBD Gnotobiotic Core, an integral Center component since 1988, is a highly utilized resource that
provides CGIBD members with germ-free (sterile), selectively colonized and fecal transplanted mice to
precisely study host-environmental interactions and bacterial functions. This world-class facility allows CGIBD
members, their trainees and collaborators to perform cutting edge investigations using wild-type (WT) and
genetically engineered transgenic, knockout and reporter gnotobiotic mice in the absence of microbiota [germ-
free (GF)] or colonized with single bacterial species, including gene deletion/complemented mutants, defined
consortia of murine or human bacterial species or transfer complex fecal microbial communities from
experimental mice or humans (microbiologically humanized mice) with dysbiosis to study disease
pathogenesis. The two Gnotobiotic Core branches, one at UNC-Chapel Hill and the other at the NC State
University College of Veterinary Medicine provide GF or gnotobiotic mice and associated technical services, to
CGIBD members, associate members, and new investigators at each location. We maintain 28 GF mouse
strains and lines, including WT, knockout, transgenic, and reporter mice. The specific aims of the Core are: 1)
Provide GF or selectively colonized (gnotobiotic) WT and mutant mice, their tissues and cells. 2) Derive
additional GF WT and genetically engineered mouse strains. 3) Consult with investigators to optimize
experimental design and implementation and provide technical services. 4) Support studies for new
investigators to generate key data for grant applications. 5) Develop a library of fully characterized bacterial
strains and complex human and murine fecal communities to facilitate reproducible results in gnotobiotic
studies. This facility and the combined expertise of the Directors, Balfour Sartor, UNC-CH and Sue Tonkonogy,
NCSU provide Center members with an unparalleled resource to perform innovative, mechanistic research to
identify microbial contributions to GI homeostasis, disease, injury, and repair.